University of Michigan O'Brien Kidney Translational Core Center

ABSTRACT – CENTER OVERVIEW
In order to rapidly develop effective therapies to prevent or reverse progression of chronic kidney disease
(CKD), the University of Michigan O'Brien Kidney Translational Core Center will support the full spectrum
of a translational pipeline providing resources to basic and clinical investigators in our Institutional and
International Research Bases using a 3-pronged approach:
 Expansion of our unique CKD cohort combined with its longitudinal tissue, urine and serum
biobanks to allow our research base investigators to investigate the molecular causes and
endpoints of chronic kidney diseases;
 Dissemination and support of the most modern and powerful systems biological approaches for
research base investigators to help them effectively identify novel and robust biomarkers,
endpoints and targets for diagnosis and treatment of CKD;
 Expert analysis and integration of cohort and systems data for our research base investigators
through the use of sophisticated bioinformatics and database integration that promote
identification of specific pathways and targets for treatments for individuals or groups of subjects
with CKD.
The Center's aims are to:
1) Expand translational and systems biological approaches to kidney disease research by
expanding the Center's CKD deep clinical phenotyping and biobanking efforts through the Clinical
Phenotyping and Resource Biobank Core (C-PROBE);
2) Introduce, stimulate and apply state-of-the-art systems biological approaches to kidney disease
research studies by our Institutional Research Core investigators through the use of sophisticated
but user-friendly genetic, transcriptomic, proteomic, metabolomic and lipidomic approaches
through the Applied Systems Biology Core;
3) Enhance the understanding of complex kidney diseases and the multi-scalar data sets that
accompany systems biological approaches to their functional implications regarding kidney
disease development, diagnosis, progression and therapeutic potential through the Data Analytic
Services Core (DASC);
4) Expand worldwide outreach efforts via Nephroseq and tranSMART;
5) Use the Kidney Educational Enrichment Programs and the Pilot and Feasibility Program to entice
trainees and faculty into kidney research and support our research bases in their ongoing kidney
research.

Public health relevance
PROJECT NARRATIVE Chronic kidney disease (CKD) remains a major health problem that causes substantial disability and premature death. The University of Michigan George M. O'Brien Kidney Translational Core Center will provide researchers the opportunity to utilize advanced technologies by providing the necessary infrastructure and tools to improve care of patients with CKD. Through its research cores, enrichment activities, and pilot and feasibility grant programs, it will enable new discoveries and enhance scientific progress supporting cutting-edge basic, clinical and translational research by its highly interactive research base.